Digital Mindfulness Meditation-enhanced Cognitive Behavioral Therapy (CBT-MM) for Binge Eating Disorder

PROJECT SUMMARY/ABSTRACT
Binge eating disorder (BED) is a prevalent disorder, affecting 3.5% of Americans. BED is maintained by two-
pathways: (1) dietary over-restriction and (2) emotion dysregulation. Current treatments for BED, such as
Cognitive Behavioral Therapy (CBT) produce suboptimal results because they only target over-restriction.
Mindfulness meditation (MM) targets emotion dysregulation and could thus be an important addition to CBT for
Eating Disorders. Furthermore, digital delivery of an MMT for BED would offer unprecedented scalability, but
there are no current digital MMTs for BED. The current K23 proposal involves developing a digital Mindfulness
Meditation-enhanced Cognitive Behavioral Therapy (CBT-MM) for BED via two phases. CBT-MM will target the
two different mechanisms of BED (dietary over-restriction and emotion dysregulation). In Phase 1, I will finalize
the development of digital CBT-MM via interview-based user testing. In Phase 2, I will conduct a pilot feasibility
randomized controlled trial (RCT). For the RCT, 40 individuals with BED recruited nationally will be randomized
to digital: 1) CBT-MM (n = 20); or 2) an already developed digital CBT treatment (iTakeControl) only (n = 20).
The RCT will be conducted virtually, with video-based assessments at baseline, mid- and post-treatment, and
3-month follow up. Aim 1 is to develop digital CBT-MM. Aim 2 is to evaluate feasibility and acceptability. Aim 3
is to measure within-group changes from pre-to post treatment on binge eating remission, binge eating
frequency, weight, quality of life, depressive symptoms, emotion dysregulation, dietary over-restriction, and
trait mindfulness. This project has the potential for developing an innovative, theory-driven, efficacious, and
scalable mindfulness-based treatment for BED that can have a large public health impact. To carry out this
K23, I will receive mentorship from a leading team of experts in the areas of mindfulness, CBT for eating
disorders, technology-based treatment development, and qualitative methods. This K23 will specifically
facilitate my training in: (1) developing and refining mindfulness-based eating and weight disorder treatments;
(2) technology-based treatment development, (3) formalized training in conducting clinical trials, and (4)
qualitative methods for intervention development. This award will serve as a launching point for my career as I
leverage the training and research skills afforded by this award to become a leader in the field of digital
mindfulness-based treatment development for eating and weight disorders.

Public health relevance
PROJECT NARRATIVE I propose to develop a novel digital treatment, Mindfulness Meditation-enhanced Cognitive Behavioral Therapy (CBT-MM), that integrates MM and CBT for the treatment of Binge Eating Disorder (BED) to target the two important mechanisms in the development and maintenance of BED: dietary over-restriction and emotion dysregulation. The current K23 proposal involves developing digital CBT-MM for BED and conducting a pilot randomized control trial to evaluate its feasibility, acceptability, and within-group changes from pre-to post treatment on indices of: binge eating remission, binge eating frequency, weight, quality of life, depressive symptoms, emotion dysregulation, dietary over-restriction, and trait mindfulness. This innovative research project has the potential to advance research on mindfulness-based treatment for eating disorders.